Exploring novel strategies for immunoprevention of estrogen receptor negative breast cancer

Summary
In 2020, breast cancer has surpassed lung cancer as the most commonly diagnosed cancer in women.
Compared to estrogen receptor (ER)-positive breast cancers, ER-negative (ER-) breast cancers have worse
prognoses and no effective prevention strategies. In this study, we will explore new strategies for
immunoprevention of ER- breast cancer. Inducing potent anti-tumor immunity for prevention of poorly
immunogenic breast cancers has been highly challenging. Engagement and expansion of activated dendritic
cells (DCs) could facilitate broad and efficient anti-tumor immunities. However, certain existing DC stimulators
(e.g., agonists of toll-like receptors and STING) also triggered adverse immune responses. For cancer
prevention, it is imperative to develop safe and effective approaches to boost DC immunity. To this end, we
screened for dietary supplements that increase DC activities and identified natural vitamin E (VitE) as a stimulator
of DC functions. Excitingly, we found that breast cancer patients who took VitE during immunotherapies had a
significantly better survival rate and improved therapeutic response than patients who didn’t take VitE,
suggesting that VitE administration may potentiate anti-tumor immunity. Indeed, systemic (oral) administration
and local (at injection site together with cancer vaccines) delivery of VitE significantly prolonged tumor-free
survival in ER- mammary tumor mouse models that didn’t respond to cancer vaccines alone. These data led us
to hypothesize that VitE administration, via reinforcing DC activation and antigen presentation, enhances
immunoprevention of ER- breast cancer by cancer vaccines. We will test whether VitE could enhance cancer
vaccine-induced immune surveillance and prevent/delay tumor initiation/progression in genetic engineered
mouse models of (HER2+ and basal-like subtypes) ER- mammary tumors and the CD34+ humanized mouse
models (for prevention of human ER- breast cancers) (Aim1). As a proof of concept, we will primarily use a triple-
antigen (tumor associated antigens neu/IGFBP-2/IGF-IR) peptide vaccine (TAVac) for proposed studies since
TAVac has shown partial efficacy in delaying tumor progression in ER- mammary tumor mouse models.
Importantly, corresponding DNA vaccines against human HER2/IGFBP-2/IGF-IR are currently under phase I/II
clinical studies for prevention of HER2+ and HER2- breast cancer recurrence. To gain mechanistic insights into
how VitE potentiates anti-tumor immunity, we will investigate i) the global effect of VitE on the immune cell
landscape by mass cytometry (CyTOF); ii) the impact of VitE on DC and T-cell subset compositions, functionality
and signaling networks; iii) major immunophenotype changes critical for VitE-enhanced immunoprevention; iv)
how VitE prompts antigen processing/presentation in DCs and whether VitE functions through SHP1, a critical
DC checkpoint (Aim2). Finally, we will test novel strategies to further improve the immunoprevention efficacy
against ER- mammary tumors (Aim3). If successful, our strategies could be readily tested in future clinic trials
for immunoprevention of breast cancer, particularly, for women at high risk for ER- breast cancer.

Public health relevance
Narrative-Relevance This R01 application tackles one of the unmet challenging problems in the breast cancer field: prevention of estrogen receptor-negative (ER-) breast cancer. The major goal of this research is to determine whether and how vitamin E administration via both local and systemic deliveries would enforce dendritic cell antigen presentation, increase tumor antigen-specific T-cell response, boost effector memory T-cells, and potentiate cancer vaccine-induced immunoprevention against ER- mammary tumor and human breast cancer. If preclinical studies are successful, our new strategies could be fast-track translated into breast cancer immunoprevention clinical trials for women at high risk for ER- breast cancer.